INTRAVENOUS CGP-42466 IN PATIENTS WITH PAGET'S DISEASE OF BONE

The purpose of this study is to determine the safety and tolerability of a new bisphosphonate in the treatment of Paget's disease of bone.